Structural Analysis of Corepressor Binding to PPARγ

? DESCRIPTION (provided by applicant): The nuclear receptor transcription factor PPARγ is an established target for FDA approved drugs for patients with type II diabetes mellitus (T2DM). These drugs and numerous other known ligands that bind PPARγ increase insulin sensitivity T2DM patients. Most of the PPARγ-binding drugs also display adverse side effects, including increased risk of bone fractures, weight gain, and heart disease. Despite these negative indications, PPARγ remains an important T2DM therapeutic target. Detailed understanding of how ligands affect PPARγ activity may facilitate the development of new drugs with fewer adverse effects. The transcription of PPARγ target genes is affected, in part, by small molecule ligands that bind to its ligand-binding domain (LBD) and change the interaction between PPARγ and coregulator proteins (corepressors and coactivators). In the inactive transcriptionally repressive form, PPARγ is bound to corepressor proteins. Binding of an agonist ligand, including FDA approved drugs that target PPARγ, causes a conformational change that releases corepressors and allows binding of coactivators; this generally results in an increase the expression of PPARγ target genes. While many crystal structures have been reported for PPARγ bound to coactivator peptides and agonist ligands, no structural data has been reported for PPARγ bound to a corepressor. Agonist ligands stabilize the activation function-2 (AF-2) surface, decreasing binding affinity for corepressors while increasing affinity for coactivators. The stabilized AF-2 surface with coactivators likely explains the numerous PPARγ crystal structures bound to coactivator peptides. However, our preliminary data show that a dynamic AF-2 surface, which samples multiple conformations, facilitates corepressor binding. The dynamics of the AF-2 surface when bound to a corepressor may explain why no crystal structure of PPARγ bound to a corepressor has been reported, since the dynamic surface could inhibit crystal formation. Using a multidisciplinary approach combining NMR, biochemical, biophysical and cell- based functional methods we seek to report the first structural understanding of how corepressor proteins bind PPARγ. The connection of PPARγ corepressor binding to functional effects could aid in the design of novel compounds targeting PPARγ with lower unwanted side effects profiles.

Public health relevance
PUBLIC HEALTH RELEVANCE: Drugs that target a nuclear receptor transcription factor called PPARγ increases insulin sensitivity yet also exhibit adverse side effects such as bone brittleness and heart disease. Our proposal seeks to study a missing piece of information in understanding how drugs affect PPARγ activity. This information could provide useful information that may help develop drugs that exhibit the positive attributes of PPARγ activation without the unwanted side effects.